Reducing Uninsurance by Addressing Administrative Burdens in the Health Insurance Marketplaces

PROJECT SUMMARY/ABSTRACT
Over 27 million Americans remain uninsured in 2022, and millions more have lost Medicaid coverage with the
end of the Public Health Emergency in 2023. Over 40% of uninsured persons were eligible for large subsidies
to obtain coverage through the Health Insurance Marketplaces created by the Affordable Care Act. Health in-
surance is critical to providing access to care and improving health outcomes. While the American Rescue Plan
Act greatly reduced affordability barriers to Marketplace coverage, other key barriers to coverage remain un-
addressed. Administrative burdens—the compliance, learning, and psychological costs people face when inter-
acting with government services—have a large effect on health insurance coverage take-up. Despite the Market-
places’ critical role in providing health insurance coverage to Americans during the COVID-19 pandemic, lim-
ited research exists on the effects of administrative burdens on Marketplace enrollment. This proposal’s objec-
tive is to assess how different types of administrative burdens impact Marketplace enrollment. The applicants
will use state-of-the-art research methods from economics, public administration, and anthropology to address
three specific aims: (1) determine if eliminating premium payment-related compliance costs affects reenroll-
ment in Marketplace coverage; (2) determine whether reducing the burden of information costs through adver-
tising affects Marketplace coverage take-up; and (3) create a person-centered understanding of how compli-
ance, information, and psychological costs erect barriers to Marketplace coverage. Aims 1 and 2 will use Mar-
ketplace enrollment data and causal inference approaches; Aim 3 will use semi-structured interviews in three
diverse states, Arizona, Connecticut, and North Carolina, to study administrative burdens. This mixed methods
research addresses a critical need for evidence on cost-effective policies that can reduce the number of unin-
sured, who disproportionately consist of AHRQ priority populations, including racial and ethnic minorities and
rural and low-income populations. In so doing, this proposal is directly responsive to AHRQ’s interest in re-
search on health insurance coverage, access and affordability, and its special emphasis notice on health services
research to advance health equity. It also is responsive to the President’s executive order on reducing adminis-
trative burdens. Results will provide state and federal policymakers with easily implementable approaches to
reducing the uninsured rate by making the process of Marketplace enrollment less burdensome. This proposal
is particularly timely with the end of the Public Health Emergency, which will require millions of former Medi-
caid enrollees to successfully navigate Marketplace administrative burdens to remain insured. The applicants
will directly disseminate findings to Marketplace policymakers and administrators to facilitate translation of
the proposed research into policies that reduce the number of uninsured.

Public health relevance
PROJECT NARRATIVE Administrative burdens—the compliance, learning, and psychological costs people face when interacting with and applying for government services—are a key barrier to obtaining health insurance for the over 11 million uninsured Americans that are eligible for subsidized coverage in the Health Insurance Marketplaces created by the Affordable Care Act, as well as millions of Americans that lost Medicaid coverage at the end of the Public Health Emergency and are now eligible to enroll in subsidized Marketplace coverage. This project will use com- plementary quantitative and qualitative research methods from economics, public administration, and anthro- pology to: (1) determine whether premium payment-related compliance costs affects reenrollment in Market- place coverage; (2) determine whether reducing the burden of information costs through advertising affects Marketplace coverage take-up; and (3) create a person-centered understanding of how compliance, infor- mation, and psychological costs erect barriers to Marketplace coverage. This project is relevant to public health because it will identify policy changes state and federal policymakers could make to increase Marketplace health insurance take-up that are not dependent on federal legislation or significant state budget outlays, thereby providing health insurance coverage, which has been shown to reduce mortality, to the remaining un- insured, who disproportionately consist of AHRQ priority populations.